Elucidating How Neuropeptides Communicate Chemosensory Information During Developmental Decision Making

Project Summary / Abstract
Our framework of understanding communication within the nervous system has traditionally focused on
neurotransmitter-based synaptic transmission, thereby leaving out the importance of neuropeptides and their
cognate receptors as modulatory elements. It is becoming increasingly clear that neuropeptides regulate
important neurological processes by mediating communication between neurons and across tissues.
Accordingly, neuropeptides have been implicated a broad array of neurological disorders including
neurodegenerative diseases such as Alzheimer’s and Parkinson’s Disease. However, the precise molecular
mechanisms that explain how neuropeptides participate in neurotransmission are not well understood. The
overarching goal of this proposal is to use the roundworm Caenorhabditis elegans as a model organism to
further our understanding of how neuropeptides communicate information within a densely connected nervous
system. In this proposal, I plan to delineate a neuropeptide-based signaling mechanism that transmits
chemosensory information in order to make an important developmental decision. Specifically, this
proposal will study how neuropeptides participate in the dauer exit decision, which is an irreversible
developmental decision in which C. elegans that have previously entered the stress-resistant diapause state
(termed dauer) choose to exit from that state and return to their reproductive life cycle as late stage larval
worms. Aim 1 of this proposal seeks to broadly identify and characterize neuropeptide genes that are essential
for the dauer exit decision. Aim 2 takes a single neuron approach and focuses on a specific chemosensory
neuron essential for dauer exit: the ASJ neuron. In this aim, I will identify which neuropeptide(s) ASJ relies on
in order to mediate the dauer exit decision. Finally, in Aim 3, I examine how neuropeptides themselves are
regulated in response to appropriate external stimuli by using reporter technology to in-depth study the
regulation of one particular neuropeptide gene in the ASJ neuron demonstrated to be important for dauer exit.
Collectively, all three aims will portray a clearer picture of how neuropeptides serve as a bridge between
chemosensory inputs and downstream developmental programs in an organism such as C. elegans.

Public health relevance
Project Narrative Neuropeptides are a conserved class of neuromodulators implicated in various neurological disorders ranging from chronic pain to neurodegenerative diseases. While their role in mediating diverse neuronal processes is well-appreciated, the precise molecular mechanisms that govern how neuropeptides communicate information across neurons and tissues, as well as how neuropeptides themselves are regulated in response to environmental flux, remains poorly understood. Using C. elegans as a model organism, I will elucidate a neuropeptidergic signaling pathway that governs an important C. elegans developmental decision, which will significantly enhance our molecular understanding of how neuropeptides fit within the framework of nervous system communication.